Films for Indigenous Cancer Health: Roswell Park Comprehensive Cancer Center, Indigenous Nations, and Health Communications

Project Summary/Abstract
Cancer and health-related community outreach and education efforts progressively rely on digital media to reach
and inform important target audiences. To address cancer disparities among Indigenous populations the aim of
this project creates a series of health communication films with social media influencers and Indigenous icons
for use in community-based health centers and is guided by the Transportation-Imagery Model of Narrative
Communication. The project will integrate community-based practice, prevention messaging, cancer screening
information to increase cancer-based knowledge, intent, and behaviors among Indigenous communities. This
will be accomplished by collaborative efforts from an NCI-designated cancer center’s Department of Indigenous
Cancer Health, Community Outreach and Engagement, and Health Communications Resources alongside
Indigenous media networks and community-based film companies. Objectives include film creation, hosting
screenings, panel discussions and the embedment of films into the cancer center’s Indigenous outreach,
engagement, and prevention digital repository. Evaluative efforts include co-produced films guided by an inter-
tribal community advisory board, pre-post surveys on knowledge, attitude, cancer prevention, and screening
behaviors. The long-term goal is the continuance of community outreach for Indigenous communities, Indigenous
urban centers with sustainable integration into Indigenous services delivery systems Overall, results are
expected to increase community-based collaborative efforts through health messaging.

Public health relevance
Project Narrative Cancer health education rely on digital media to inform. To address cancer disparities among Indigenous populations health films were co-created between a cancer center health communications team and Indigenous influencers to increase cancer-based awareness.